SUPPORT FOR THE DIET, NUTRITION, AND CANCER PROGRAM

The purpose of this contract is to provide intervention clinical trials support. The primary objectives are to provide analytical, data management, computer programming and coordination support for intervention trials in DNCP.